Apoptotic Proteins as Molecular Modulators of Stem Cell Fate

DESCRIPTION (provided by applicant): Despite the clinical importance of embryonic stem (ES) cells for regenerative medicine, many key biological features of these cells remain unexplored. We recently discovered that core components of the apoptotic machinery are differentially regulated in ES cells and that this unique regulation is critical for the ability ofES to respond rapidly to DNA damage. In particular, we found that undifferentiated human (h) ES cells are primed for rapid apoptosis by maintaining the pro-apoptotic protein Bax in its active conformation at the Golgi. Remarkably, we found that just two days of differentiation induced significant changes: Bax was no longer in an active state and the cells were no longer highly sensitive to DNA damage. Thus, the apoptotic machinery undergoes extraordinary changes even in the earliest stages of hES cell differentiation. Rather unexpectedly, I found that changes in these apoptotic components affected not only the thresholds of apoptosis but also the ability of ES cell to maintain self-renewal. Specifically, I found that levels of the anti- apoptotic proten Mcl-1 are markedly reduced with early differentiation and that inhibiting Mcl-1 alone was sufficient to induce differentiation of hES cells. These results have lead me to hypothesize that apoptotic proteins that were previously thought to be involved only in processes of cell death, are molecular switches controlling stem cell fate. My overall plan is to investigate the molecular intersection between apoptosis and stem cell differentiation with the goal of determining whether these pathways are hijacked by cancer stem cells for the dual purpose of resisting apoptosis and maintaining self renewal. Specifically, in Aim 1 I will examine the pathways that regulate Bax function during ES cell differentiation. My results also show that reprogramming of fibroblasts into induced pluripotent stem (iPS) cells is coupled with increased sensitivity to apoptosis. I will examine how the pluripotency transcription factors affect apoptosis thresholds. In Aim 2, I will focus my studies on Mcl-1 to determine the mechanism by which Mcl-1 regulates self-renewal in ES cells. In Aim 3, I will use a model of glioblastoma cancer stem cells to determine whether inhibition of Mcl-1 activity can be used as therapeutic tool to simultaneously increase the sensitivity to apoptosis and restrict the self-renewal capability. These studies will undoubtedly uncover critical aspects of apoptosis regulation in ES cells and reveal key features of stem cell biology that can have significant impact for cancer therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Human embryonic stem (hES) cells are crucial to the development of an organism and therefore must be poised to undergo rapid cell death if exposed to deleterious conditions such as DNA damage. Embryonic stem cells can be differentiated into any cell in the body. Surprisingly, I found that upon differentiation, hES cell are no longer sensitive to DNA damage. This adaptation is likely critical for ensuring the integrit of the developing embryo, however, little is known about how these cells regulate the cell death machinery during the maintenance of self-renewal or differentiation. Importantly, my recent results indicate that apoptotic proteins have a novel function in stem cell biology by promoting and regulating the ability of these cells to self-renew. These results have implications in cancer biology where cancer stem cells are shown to be highly resistant to cell death but also are capable of uncontrolled self-renewal. My proposal seeks to examine the dual function of apoptotic proteins as molecular modulators of stem cell fate with the goal of identifying new targets that can be used to develop novel cancer therapies. The written critiques of individual reviewers are provided in essentially unedited form in this section. Please note that these critiques and criteria scores were prepared prior to the meeting and may not have been revised subsequent to any discussions at the review meeting. The "Resume and Summary of Discussion" section above summarizes the final opinions of the committee __SpecificAimsTextDelimiter__ SPECIFIC AIMS During development, cells of the inner cell mass (ICM) proliferate rapidly and differentiate into every cell precursor in the organism, while maintaining a delicate balance between division, multipotency and apoptosis. Achieving this balance is likely dependent on crosstalk between these fundamental stem cell signaling pathways. How this balance is maintained is relevant not only to development, but also to cancer, because cancer stem cells are implicated as drivers of tumor progression. The main mediator of cell death is Bax, a pro-apoptotic protein that is regulated by direct activators, anti- apoptotic proteins and sensitizers (inhibitors of anti-apoptotic proteins). While most mitotic cells maintain Bax in an inactive conformation in the cytosol, we found Bax to be constitutively active at the Golgi in undifferentiated human embryonic stem (hES) cells and to translocate rapidly to the mitochondria upon DNA damage, with all cells dying by six hours. Remarkably, after only two days of differentiation, hES cells significantly increase their resistance to apoptosis. I found this increased resistance to be accompanied by loss of constitutive Bax activation as well as striking global changes in the levels of various apoptotic proteins. Rather unexpectedly, I found that modulation of these apoptotic components affected not only the thresholds of apoptosis but also the ability of ES cell to maintain self-renewal. This is particularly interesting since several apoptotic proteins have been shown to be either inactivated or overexpressed in cancers. I propose that this deregulation, which was thought to only reflect the increased resistance of these cells to apoptosis, also modulates the ability of cancer stem cells to self-renew and/or differentiate. I found that levels of the anti-apoptotic protein Mcl-1 are markedly reduced at early stages of differentiation and that inhibiting Mcl-1 alone was sufficient to induce differentiation of hES cells. Based on these observations, I propose that apoptotic proteins are subjected to strict regulation during differentiation to modulate their function in maintaining self-renewal and pluripotency. I will explore how the new function of apoptotic proteins in self-renewal is dysregulated during the acquisition of a cancer stem cell phenotype in glioblastoma. My general hypothesis is that key components of the apoptotic machinery also function as molecular switches driving stem cell fate. The role of apoptotic proteins in maintaining self renewal and the regulation of these apoptotic components during the early stages of development and during the acquisition of a cancer stem cell phenotype remains unexplored and will be the main focus of this proposal. Aim 1 (K99 Phase): What is the role of the apoptotic machinery during differentiation and de- differentiation? Apoptotic proteins undergo global changes even at the early stages of differentiation, that when inhibited affect self-renewal and pluripotency capabilities of stem cells. 1a. Define the specific changes to the apoptotic machinery during differentiation. 1b. Examine whether pluripotency transcription factors (pTFs) regulate the apoptotic pathway 1c. Determine whether the apoptotic components are important in maintaining self-renewal Aim 2 (K99/R00 phase): How does Mcl-1 contribute to stem cell self-renewal and differentiation? I found the anti-apoptotic protein Mcl-1 to be rapidly decreased during differentiation. Recently, a new function for Mcl- 1 at the mitochondria was described. Strikingly, blocking Mcl-1 activity in undifferentiated hES cells induces loss of pluripotency markers and engaged differentiation. These results point to Mcl-1 as a critical factor involved in maintaining self-renewal. I will examine this phenomenon by addressing the following subaims: 2a. Characterize the specific effect on stem cell fate induced by Mcl-1 inhibition. 2b. Identify which key function of Mcl-1 at the mitochondria is critical for maintaining stem cell self-renewal Aim 3 (R00 phase): What is the role of the cell death machinery in the acquisition of a cancer stem cell (CSC) phenotype? I propose that apoptotic components are often dysregulated in cancers for two purposes: to increase cell death resistance (a hallmark of cancer cells) but also to increase self-renewal and to inhibit differentiation of tumor initiating cells. I will specifically use the model of glioblastoma cancer stem cells to uncover this new role of apoptotic proteins in self-renewal and differentiation, with the goal of finding novel strategies to target glioblastoma cancer stem cells. 3a. Examine whether the apoptotic machinery is dysregulated during the acquisition of a CSC phenotype 3b. Test if inhibition of Mcl-1 activity promotes differentiation of glioma cancer stem cells and whether this strategy can be used to block glioblastoma in vivo A systematic understanding of the dynamic changes to the apoptotic machinery that occur during differentiation programs will not only be useful to understand basic concepts of stem cell self renewal and pluripotency but also will shed light onto new molecular mechanisms that could lead to stem cell transformation in cancer.